High-density microfiber interfaces for deep brain optical recording and stimulation

Project Summary This project seeks to develop a high density, minimally invasive optical microﬁber array for long-term recording and manipulation of brain activity. Optical methods have become a cornerstone of modern brain science in animal models, and hold great potential for future human prosthetic devices. However, light scattering severely limits optical approaches for deep brain recording and stimulation. Current photometry methods of implanting optical ﬁbers into deep brain areas work with relatively large ﬁbers designed for the communications industry (125 μm). This project builds an optical microﬁber array to record from and stimulate deep brain areas. The device achieves a high channel count with sub-cellular (7 μm) optical microﬁbers distributed in three- dimensional volumes of the brain. To implant the device, individual microﬁber light guides are bundled together, strengthening each ﬁber through mutual support. During insertion into the brain, the bundle of microﬁbers splays and each microﬁber follows a distinct path into the brain as it is deﬂected by tissue inhomogeneity. This process is hypothesized to preserve the minimally invasive properties of a single 7 μm ﬁber. Prototype designs reveal healthy neurons in close proximity to the implanted microﬁbers, and high signal to noise recordings in vitro. The project builds on preliminary data to test high channel count devices for both recording and stimulation. To advance this technology, the project involves a series of aims to characterize tissue response to high channel count implants, develop a rotary ﬂuorescence microscope to interface with the array, and benchmark the performance of the device for both recording and stimulation of genetically encoded constructs in deep brain regions.

Public health relevance
Project Narrative Communications grade optical fibers provide a powerful method to record and stimulate activity in deep brain areas. However, the method typically provides only one or a few channels of information, since tissue damage limits the number of fibers that can be implanted. This project develops and tests an implantable optical interface consisting of microfibers whose cross section is 2-3 orders of magnitude smaller than optical fibers now is use, providing a stable optical interface to deep areas of the brain critical for basic brain research.